Exploring Mechanisms of Change in a Pilot Trial of the RUBI Program in Educational Settings

ABSTRACT
Approximately 50% of children with autism spectrum disorder (ASD) exhibit disruptive behaviors such as
tantrums, aggression, and noncompliance that significantly impact meaningful engagement in academic tasks
and with peers as well as result in placement in more restrictive classroom settings. Current school-based
behavioral management approaches, while effective, are time-consuming and resource-intensive. There is a
need for efficient and pragmatic intervention models that build capacity with direct care providers, streamline
the intervention process, reduce the need for intensive behavioral supports, and increase the number of
children with ASD who can be served. The RUBI program is an evidence-based parent-mediated intervention
that improves disruptive behavior in children with ASD. Considering schools serve as the primary intervention
setting for children with ASD, and paraeducators often struggle to address challenging behavior in the
classroom, there is an opportunity to meaningfully improve care by moving RUBI from delivery in clinic to
school and from parent to paraeducator. The current study is an extension of a recently completed NIMH-
funded human-centered design study targeting modification of RUBI to ensure its appropriateness for use in
educational settings. The proposed three-year pilot randomized trial aims to test the effectiveness of the newly-
redesigned paraeducator-delivered RUBI for use in Educational Settings (RUBIES) intervention compared to
usual care training in reducing disruptive behavior in 80 elementary-school children with ASD. Given the critical
need to understand not just whether, but also how interventions work, this study also will examine
paraeducator- and child-level mechanistic pathways of the RUBIES intervention. Successful completion of the
proposed study will allow for a large-scale effectiveness trial of RUBIES in public schools to reduce disruptive
behavior, which has the potential to improve the quality of life for children with ASD across the country.

Public health relevance
PROJECT NARRATIVE This randomized pilot effectiveness trial will examine the feasibility and impact of a redesigned paraeducator- delivered intervention, RUBI in Educational Settings (RUBIES), on disruptive behavior in elementary-school children with ASD, as well as explore mechanistic pathways of the RUBIES program. The proposed study’s collaboration with publicly funded educational systems has the potential to impact service delivery and make educational supports readily accessible to the public, which may lead to more optimal outcomes and reduce the need for ancillary services, thereby lowering cost of care.